Strengthening Injury Control Research in Ghana and West Africa

ABSTRACT
The broad goal of this competing renewal proposal is to strengthen the capacity for injury control research in
academic institutions in Ghana, building a cadre of qualified researchers, with growing collaborations among
West African countries. The project will increase capacity to generate evidence that will be translated into
effective activities and implementable policy across the spectrum of injury control.
The specific aims are:
1. Develop and implement high-quality short, intermediate, and long-term training opportunities in injury
control within Ghana and West Africa, to train future academic leaders in the field. We will provide 4 MPH
degrees, 5 PhD degrees, and 3 post-doctoral fellowships (oriented for junior faculty) comprising 3 months
of structured training and 2 years of mentored research. We will conduct 15 short (1-2 day) courses
reaching over 500 participants and 20 distance learning sessions (1-2 hours) reaching over 1,000 West
Africa-wide participants.
2. Engage junior researchers in innovative, mentored research to generate evidence to strengthen the
policy and practice of injury control in Ghana, West Africa, and low- and middle-income countries widely.
3. Increase the capacity for injury control research at the Kwame Nkrumah University of Science and
Technology (KNUST), and in other academic institutions, government agencies, and non-government
organizations in Ghana. The number of KNUST departments that have at least one faculty member with
MPH/PhD training with a focus on injury, with related publications, who are involved with international
injury research networks, and who head experienced, accomplished research teams will increase from 4
currently to 6. The number of such departments at University of Cape Coast and University of
Development Studies will increase from 1 department currently to 2 each.
Training and research will address the spectrum of injury control (surveillance, prevention, care). This program
builds on a 30-year collaboration for injury research among KNUST, other institutions in Ghana, and the
University of Washington. The past 15 years have been under the auspices of the Fogarty TRAUMA program,
for which KNUST has been the prime recipient for the past 5 years. New plans for the coming cycle include: 1)
address injury problems that we have not yet addressed sufficiently, including drowning, violence, and injuries
to vulnerable populations (children, elderly); 2) increase emphasis on PhDs and junior faculty; 3) introduce
training and options for clinical trial research; and 4) found a multi-disciplinary Kumasi Injury Prevention Center
that will increase synergies among different KNUST departments and government agencies working in injury.
At the end of the project, scholars will have competed successfully for funding, contributed to a growing base
of policy-relevant research, and taken up faculty positions at institutions throughout Ghana and West Africa.

Public health relevance
NARRATIVE In stark contrast to the reduction in injury deaths among industrial nations, low and middle-income countries have experienced growing rates of injury, especially in sub-Saharan Africa. This proposal builds upon long- standing collaborations developed among the Kwame Nkrumah University of Science and Technology (KNUST), other Ghanaian institutions involved with injury control, and the University of Washington, in order to (i) develop a cadre of trained injury research leaders, and (ii) engage junior researchers in innovative, mentored injury related health research to reduce the burden of injury and strengthen the practice of injury control; and (iii) build capacity for injury control in Ghanaian and other West African institutions. We will develop, expand and consolidate existing collaborative research and training networks by integrating researchers from Ghana, other West African nations, the UW and other institutions with a shared commitment to preventing and treating injury.